Lipid Metabolism, Mitochondrial Stress, and Senescence

Project Abstract
Accumulation of senescent cells in adipose tissue, particularly visceral depots, is increasingly becoming more
appreciated as a causal factor in age- and obesity-associated metabolic dysfunction, conditions that impart a
heavy burden in terms of suffering and mortality on public health. Concomitant creation of an inflammatory milieu
is thought to facilitate the development of systemic insulin resistance. As lipid peroxidation and pertinent drivers
are shown to be associated with lifespan and age-related pathologies, I posit that resulting electrophilic lipid
byproducts can incite or potentiate senescence in adipose. Produced abundantly in adipocytes by peroxidation
of mitochondrial phospholipids, lipid aldehydes such as 4-hydroxynonenal (HNE) and 4-oxo-2-nonenal (ONE)
covalently modify nucleophilic protein residues and herein I hypothesize that carbonyl stress exerts oxidative
stress and mitochondrial dysfunction to induce the senescence program in adipose progenitor cells. Proposed
studies would represent the first efforts to thoroughly and systematically characterize the biochemistry and
cellular signaling underpinning cellular senescence brought on by lipid aldehydes.
IMR90 fibroblasts continuously exposed to lipid aldehydes for seven days exhibit initiation of the senescence
program, characterized by induction of SA-β-gal activity and enhanced expression of CDKN1A (p21Cip1), among
other senescence markers. I’ve termed this type of senescence Biogenic Lipid Induced Senescence, BLIS.
Associated with BLIS is the upregulation of an NFκB-independent subset of the putative human SASP.
Furthermore, I demonstrated that permeabilization of mitochondrial membranes by BAK/BAX channels mediate
the BLIS phenotype. The overall mechanism of lipid aldehyde associated senescence is multifaceted and likely
to involve mitochondrial protein modification, as I observed hallmarks of aberrant mitochondrial function
concomitant with development of BLIS markers and alkylation of mitochondrial proteins. Indeed, 4-HNE
exposure effects reduced mitochondrial spare capacity and increased ADP:ATP ratios. Taken together,
preliminary data suggest that reactive lipid aldehydes can induce cellular senescence and that adipose
senescence may be linked to lipid-mediated senescence induction in fat tissue. Proposed work can be broken
down into two aims: in my first aim, I will use a proteomics-based approach to define targets of mitochondrial
carbonylation during obesity and aging and in my second aim, I will investigate the role of mitochondrial stress
and signaling on adipose senescence. During proposed experiments, I will build vital skills as a researcher,
most importantly in proteomics data analysis and hands-on in vivo work with mouse models. Backed by a
mentoring committed composed of faculty active in the field of aging research and spanning multiple departments
at the University of Minnesota, I am confident an F32 fellowship will facilitate both my development as a
researcher and novel, impactful research.

Public health relevance
Project Narrative Insulin resistance, a common and serious health problem, can be associated both with obesity and old age. Recent discoveries point to dysfunction in fat tissue as a culprit; proposed studies will build on those findings and explore the altered biochemistry of fats that leads to that dysfunction. Insights from these studies will inform therapies for age- and obesity-acquired insulin resistance, for which treatment options are currently limited.